UPCC 7897 WEEKLY LIPOSOME ENCAPSULATED DOXORUBICIN (LED) IN HORMONE

This ongoing trial seeks to determine the MTD of LED in prostate cancer patients. To date dose limiting toxicity has not been reached. The trial continues to have patients. Secondaary endpoints include analysis of pharmacokinetics of weekly LED and assessment of anti-trust activity.